Single cell transcriptomics of nerves that lack Remak bundles

PROJECT ABSTRACT
Schwann cells (SCs) are neural crest derived cells whose primary function is the support and protection of
neurons in the peripheral nervous system. SCs can be divided into two subtypes: myelinating and non-
myelinating. Myelinating SCs form 1:1 relationships with neurons and ensheath them in myelin to provide rapid
conduction of nerve impulses, such as those required for transduction of proprioception and touch. In contrast,
non-myelinating SCs typically bundle multiple axons into nerve structures known as Remak bundles, which
support the cells but do not speed transmissions. Individuals with dysfunction of SCs exhibit a variety of
phenotypes which may include decreased sensation, weakness, and pain, and these diseases are among the
most common inherited conditions in humans. In addition, SCs are also the cell type targeted for tumorigenesis
in the Neurofibromatosis syndromes (NF1 and NF2) which ae associated with benign and malignant tumors of
the peripheral nerves and other locations. Rac1 is a small GTPase protein of the Rho family, and it has been
shown to essential for tumorigenesis in both NF1- and NF2-associated tumors, as well as other forms of inherited
Schwann cell tumors (e.g., Carney Complex). Recently, analyses of inherited SC dysfunctional syndromes have
also shown dysregulation of Rac1. To investigate the role of Rac1 signaling in SC function and tumorigenesis,
my laboratory has generated a mouse model carrying a conditionally active allele of Rac1 and performed
preliminary characterization of the effects of activation Rac1 at various stages of SC development. We observe
that activation of Rac1 in early embryogenesis enhanced cell proliferation and affects the ability of non-
myelinating SCs to form normal Remak bundles, which are completely absent from nerves with Rac1 activated
in early embryogenesis. In this R03 application, we hypothesize that Rac1 activation leads to aberrant
differentiation specifically in non-myelinating SCs without affecting the trajectory of myelinating SCs. Initial
characterization of this defect through this pilot grant application will lead to future studies with important
implications for nociception and for tumorigenesis.
To address this hypothesis, we propose the single Specific Aim to assess the differential effects of
activation of Rac1 on the transcriptomes of myelinating and non-myelinating Schwann cells. As a first
step, will compare the transcriptomes of WT SCs to the abnormal SCs in mice with SC-targeted early
activation of Rac1. Secondly, we will expand the analysis to include mice with later activation of Rac1, as these
animals appear to have morphologically and functional normal SCs. Thirdly, we will validate these data by
analyzing specific transcripts and proteins to verify the transcriptomic changes.
If successful, these studies will begin to elucidate the important molecular functions of Rac1 in mediating the
differentiation, physiologic function, and tumor implications of Schwann cells in vivo, with implications both for
understanding and treating pain, and for understanding SC tumorigenesis such as in NF.

Public health relevance
PROJECT NARRATIVE Schwann cells are neural crest derived cells whose primary function is the support and protection of neurons in the peripheral nervous system, and abnormal function of specific sub-populations of these cells can lead to abnormal sensory or motor function, or to tumors. Rac1 is a signaling molecule that functions broadly in Schwann cells, and my laboratory has generated a new mouse model in which the protein is abnormally activated in this cell type and interferes with the formation of normal populations of mature cells. In this pilot project, we will perform single cell analysis to begin to elucidate how the unregulated activation of this protein in all Schwann cells alters both the form and function of distinct populations of mature Schwann cell subtypes.